Simplifying HIV Treatment and Monitoring (STREAM2): Point-of-Care Urine Tenofovir Adherence and Viral Load Testing to Improve HIV Outcomes in South Africa

ABSTRACT
For millions of people living with HIV (PLHIV) receiving antiretroviral therapy (ART), adequate ART adherence
and routine HIV viral load (VL) monitoring are critical to ensure viral suppression and good health outcomes.
Initiation and management of life-long ART in low- and middle-income countries (LMICs) is challenging for both
PLHIV and providers in part due to the reliance on self-reported adherence and delays with lab-based VL testing,
which are part of the usual care. Drs. Drain and Garrett (co-principal investigators) recently completed a pilot
study in South Africa demonstrating that point-of-care (POC) VL monitoring for PLHIV receiving efavirenz-based
ART increased VL suppression and retention in care by 14% (95% CI 6-21%) over a 12-month period compared
to standard lab testing. However, the applicability of these findings to the context of newer, more robust
dolutegravir-based ART regimens being introduced in several LMICs, including South Africa, is not known. To
complement POC VL monitoring, we have recently completed the development and initial evaluation of a novel
POC urine tenofovir assay, in collaboration with Abbott Diagnostics, which can monitor ART adherence in clinic-
based settings in real-time. Building on our pilot study results, our objective in this application is to determine the
clinical efficacy and cost effectiveness of implementing an integrated HIV care model using POC tenofovir
adherence testing and POC VL monitoring in maintaining durable VL suppression among PLHIV receiving
tenofovir-based ART in South Africa. Our central hypotheses are that POC tenofovir adherence testing and POC
VL monitoring will improve VL suppression rates and retention in care, while being a feasible, acceptable, and
cost-effective strategy for ART management. We will objectively test our central hypotheses with three specific
aims: (1) to determine if an integrated model for HIV monitoring using a POC tenofovir adherence assay and a
POC VL test will improve VL suppression and retention in care; (2) to monitor implementation and assess patient
and provider perspectives of real-time POC tenofovir adherence testing and POC VL monitoring in South Africa;
and (3) to estimate the costs and cost-effectiveness of implementing POC tenofovir adherence testing with POC
VL monitoring, compared to no objective adherence testing and lab-based VL monitoring. To complete these
aims, we will randomize 534 participants (1:1) at ART initiation into regular POC tenofovir adherence testing with
POC VL monitoring (Arm 1) or standard-of-care with no objective tenofovir adherence testing and lab-based VL
monitoring (Arm 2). Participants will be followed to compare a primary composite outcome of VL suppression
and retention in care between the study arms at 18 months after ART initiation. This randomized controlled
implementation trial will provide crucial data on the clinical efficacy, acceptability, and cost-effectiveness of an
integrated model of POC adherence and VL testing to inform global policy on improving HIV care in LMICs.

Public health relevance
PROJECT NARRATIVE Effective management of patients on antiretroviral therapy (ART) is essential to improve patient outcomes and prevent HIV transmission, but monitoring life-long ART for over 13 million HIV-infected people has become a challenge, particularly in low- and middle-income countries (LMICs). In this study, we will evaluate a combined implementation of clinic-based point-of-care HIV viral load testing and task shifting among healthcare workers as a novel and effective strategy for managing chronic HIV care in LMICs. Our intervention will allow the most highly-trained professionals and laboratories to focus on people with new HIV diagnoses, those starting ART, and those with complication of HIV or ART, which will facilitate the expansion of ART to reach the estimated millions people who are eligible.